G-RISE at New Mexico State University

Project Summary/Abstract
The G-RISE at New Mexico State University (G-RISE@NMSU) program mission is to train PhD candidates
to become biomedical, biobehavioral, and/or bioengineering scientists prepared for leadership in the
workforce through ethical, safe, innovative, and interdisciplinary practices. Over the past 21 years, RISE at
NMSU has diversified the community of health scientists by supporting PhD degree completion for 51 NMSU
students who are underrepresented across all racial, ethnic, and minority groups. Much of the impact that
RISE has made is because of NMSU's unique status as a doctoral, research-intensive (NIH- INBRE), land
grant, minority (Hispanic) serving university with a diverse student population and a cadre of accomplished
mentors. Key outcomes of the 21-year NMSU RISE research education program are: 80.1% retention to
science careers after NMSU PhD completion; 93.4% retention to degree completion by NMSU PhDstudents;
student-authored publications; achievement of student independent support; national recognition for student
research excellence; and student entry to postdoctoral positions in R1 institutions. This new G-RISE@NMSU
application requests funds to train twelve PhD graduate scholars for the first 2-3 years of their graduate
program. Our planned program will enable completion of a PhD by >90% of the PhD scholars and their
subsequent entry to the biomedical research workforce. Trainees will be mentored in research, professional
development activities, formal courses on ethics, safety, reproducibility, and in scientific workshops that
develop cutting edge quantitative and technical skills. Mentors will be trained in how resilience and
microagressions impact URM student success and that the diversity-innovation paradox factors into their
leadership in science. Three developmental activities are planned to provide core skills to prepare students
for success in different scientific fields and careers: Activity 1: LEAD-IDEA Courses develops the research,
safety,communication and ethics skills that maximize responsible research productivity, funding success, and
degree completion in 5 years; Activity 2, START-UP (Student Training and Research through United
Partnerships) Program provides scientific and technical workshops on leadership, diversity & inclusion,
problem solving, mentoring, and metacognition. Finally, the career development programs provide employer
interaction activities and career readiness through didactic and experiential programs.

Public health relevance
Project Narrative A well-trained workforce is essential for maintaining the nation's scientific competiveness and leadership in promoting biomedical research that will improve human health. The G-RISE at New Mexico State University program will increase the number of highly trained PhD recipients who havethe skills, knowledge, creativity, and motivation to find innovative treatments for diseases and disorders that limit longevity and impair the quality of human life.